Suppression of the Immune Response in Spaceflight and Aging

Project Summary In aging, immune systems falter and the elderly are more susceptible to infection. Age related changes include decreased T-cell activation/proliferation, decreased production of IL-2 and decreased expression of IL-2Rα. These are the same key immune changes that are seen in returning astronauts who have experienced altered immune function and increased vulnerability to infection during spaceflights. Loss of immune response in aging and spaceflight has been previously identified in T cells. We have previously identified microgravity induced changes in gene expression, promoter regions, transcription factors and signal transduction pathways in human CD4+ T-cells under normal and altered gravity conditions. Our preliminary data from International Space Station (ISS) described within this proposal show that in early T-cell activation at least one miRNA was upregulated during activation in normal gravity (g), while in microgravity (μg), the induction of the miRNA was muted. Moreover, three protein targets of the miRNA had increased expression in the 1.g environment suggesting a micro RNA mechanism. The changes in immune function in the elderly occur over time and are hard to evaluate. However, the same type of changes in immune response occurs microgravity, both in astronauts and in human T-cells and is easy to measure The central hypothesis is that μg regulates MiRNA in human T-cells and that weightlessness is a novel model to study the immunosuppression seen in aging. These experiments will contribute to our fundamental understanding of the molecular mechanism of immunosuppression in spaceflight and in aging. The Specific Aims are the following: (1) Identify gene expression of miRNAs during T-cell activation (using arrays and qRTPCR) under normal gravity. (2) Identify the MiRNA(s) target genes using bioinformatics and verify the changes in expression of those targets messages (qRTPCR). We will test the ability of microgravity to induce/reduce expression of MiRNAs and their targets and verify these results using miRNA overexpression viral constructs or dsRNA. (3) Analyze the protein synthesis of the upregulated/downregulated target genes (SDS PAGE gels and Western Blot proteomics) that are affected by T-cell activation under normal gravity and microgravity conditions. (4) Compare the expression of key MiRNAs candidates and genes after activation in normal gravity and microgravity, vs. that of the lymphocytes from an older population.

Public health relevance
Project Narrative Identifying altered microRNAs and their targets in T-cells that have suppressed immune response in spaceflight but normal expression in 1g flight controls will contribute to our understanding of aging and will likely reveal important causes of immunosuppression in the elderly. In recent ISS experiments, one MiRNA is significantly downregulated in μg flown T cells when compared to onboard 1g controls; with more efficient miRNA collection, several more dysregulated MiRNAs should be identified. Because there are considerable similarities between immunosuppression in astronauts during flight and immunosuppression in the elderly, we expect that our findings will be relevant to the mission of the NIH and be broadly interesting to researchers studying molecular mechanisms of the immune response. __SpecificAimsTextDelimiter__ Research Plan 2. Specific Aims Over 50% of the Apollo astronauts had bacterial or viral infections during flight, or within 1 week of landing (1). Apollo 7 marked humanity's first experience with spaceflight infection when all three crewmembers contracted head colds during their mission (1). On Apollo 13, one astronaut contracted Pseudomonas aeruginosa and suffered from intense chills and fever (1). P. aeruginosa is an opportunistic pathogen and rarely causes disease unless the person suffers from a break in epithelia or from immune suppression. As a result, NASA implemented a preflight quarantine program that subsequently reduced the number of reported infections to one Apollo astronaut (1, 4). To this day, the preflight quarantine program is still actively used in both the US and in the Russian programs. Even with the precautions, just last year, one of the astronauts working EVA on International Space Station (ISS) had full body shingles while in orbit. Experiments from Skylab and Shuttle have confirmed that T-cells have a suppressed immune response (in vivo and in vitro) with lower T cell proliferation/activation, lower IL-2 synthesis and severely reduced IL-2Rα expression (RNA and protein); these blunted immune responses are also seen in the immunosuppresed elderly (5). Our recent ISS data shows that activation of T cells and select gene expression is decreased in microgravity when compared to onboard 1g controls (see Preliminary Results). Our long-term goal is to elucidate the molecular basis of suppression of T cell activation in microgravity. Another objective of this application is to identify altered miRNA expression (and their targets) in the lowered response of T cells in μg as compared to 1g onboard controls. Recently, we have discovered that there is altered miRNA expression in μg and we hypothesize that altered miRNAs expression may provide new information on the impaired immune response in astronauts and the elderly. A major goal of this application is to elucidate the function of MiR-21 in immunosuppression. Our research team includes experts in successful spaceflight T-cell experiments, microarrays, microarray analysis, gene array analysis, western blots and miRNA regulation. The Specific Aims of this application are as follows: 1. Identify gene expression of miRNAs during T-cell activation (using arrays, verified by qRTPCR) under normal gravity and in microgravity (μg) (Phase I simulated microgravity and Phase II μg flight) 2. Identify the miRNA(s) target genes using bioinformatics analysis of gene array data and verify the changes in expression of those targets messages (qRTPCR) in both simulated μg (Phase I) and μg flight (Phase II). We will examine the ability of μg to affect gene expression of miRNAs and their gene targets. 3. Analyze the protein synthesis of predicted target genes (Western Blots/ ELISA) that are affected by T-cell activation under normal and altered gravity conditions. 4. Compare the expression of proposed key miRNAs and genes found in μg experiments with activated T cells from older population (> 65 yrs). The proposed research is innovative because, to date, altered expression of miRNAs has never been implicated as a potential cause of immunosuppression in aging or spaceflight. Moreover, we know that we will see changes in miRNA in space because we have statistical proof that expression of one miRNA is depressed in T cells activated in μg as compared to 1g onboard controls. Since there are several similarities in clinical findings of immunosuppression in the aging and in flown astronauts, microgravity offers us a new model by which to study immunosuppression in the aging and the possibility to find new pharmaceutical targets.